An acoustofluidic device for diagnosing preclinical Alzheimer's disease

Abstract
Alzheimer’s disease (AD) is a crippling, terminal neurodegenerative illness that affects an estimated 5.5 million
people in the United States and approximately 10% of the population over the age of 65. Early symptoms of the
disease include impairment in recent memory, difficulties with expressive language, and behavioral changes
including depressed mood. Symptoms gradually worsen over time, ultimately leading to dementia and a loss of
bodily functions. Currently there is no sensitive, objective diagnostic test for the early diagnosis of AD, making it
difficult for physicians to properly screen for the disease and failing to diagnose patients that may be positive for
AD. While advances have been made in medical imaging for AD, they are extremely costly and have limited
diagnostic accuracy. In recent years, neuron-derived exosomes (30-150 nm extracellular vesicles) have
emerged as a promising biomarker for diagnosing AD. Neuron-derived exosomes found in circulation can provide
a simple, non-invasive means of monitoring the health of the central nervous system. Accumulating evidence
suggests that neuron-derived exosomes may play a crucial role in the pathology of AD by helping to spread
abnormal, potentially disease-causing, misfolded proteins throughout the brain. Preliminary studies have shown
that by analyzing the number of neuron-derived exosomes and their molecular cargo, early-stage AD patients
can be distinguished from healthy controls, as well as patients with other neurological diseases. While
researchers have made progress in identifying neuron-derived exosomal proteins and RNAs, difficulties
surrounding the isolation and analysis of exosomes have prevented their widespread use as a biomarker for AD.
Currently, there are no commercially available products capable of simultaneously isolating and analyzing
neuron-derived exosomes. The objective of this SBIR project is to overcome the limitations of existing AD
diagnostic technologies and address the unmet needs in the market by developing and commercializing an
automated, high-purity, high-yield, biocompatible exosome isolation and accurate AD biomarker detection using
acoustofluidic (i.e., the fusion of acoustics and fluid mechanics) separation and electrochemical detection
technologies. During our work on the Phase I project, we successfully demonstrated the utility and feasibility of
the proposed exosome isolation and analysis device for AD diagnosis by meeting or exceeding the target values
for each of the four key parameters identified in the Measures of Success. In Phase II, our commercialization
activities will improve the performance of the acoustofluidic chips, develop self-contained, beta-testing-ready
prototypes, and validate their performance with end users. With its advantages in automation, speed, precision,
and accuracy, the proposed acoustofluidic technology has the potential to greatly simplify and revolutionize the
diagnosis of AD. The result will be a highly sensitive liquid biopsy that will provide a comprehensive molecular
signature for AD, thus significantly improving diagnostic accuracy past existing methods and providing deeper
insight in the pathophysiology of the disease.

Public health relevance
Project Narrative Alzheimer’s disease is a devastating terminal disease with no cure, and rapidly increasing worldwide prevalence, posing a global crisis to the healthcare economy. There is a critical need to identify at earlier stages of the disease to better develop preventative and treatment strategies, however there has yet to be a standard test that is easy to admit with a high accuracy at early stages of the disease. The objective of this proposed project is to develop and commercialize an acoustic-based liquid biopsy that will serve as a platform for conducting simple blood tests with rapid processing times and high accuracy for a large suite of exosomal based biomarkers for Alzheimer’s disease present in the patients’ blood – an industry first.